Models and Tools for Dynamic Health-Relevant Diffusion over Complex Networks

DESCRIPTION (provided by applicant): Health and health behavior depend crucially on diffusion processes over social networks; both the spread of communicable diseases, such as HIV, and the diffusion of beliefs and practices that shape health behavior, such as dietary risk behavior, can be understood as generalized diffusion over (sometimes very complex and dynamic) social networks. However, despite the clear need, few of our formal analytic tools can be used to model diffusion over any but the simplest of these systems, as the mathematics for modeling diffusion over dynamic multi- relational networks are currently intractable except by direct simulation; which is often a weak foundation for generalizable knowledge; we provide a novel solution to modeling complex diffusion processes over dynamic networks by decomposing the networks into a set of tractable subsets and relation specific transmission rules. We will develop improved methods for network community detection that specifically targets understanding diffusion, and include such communities in our general framework; then test these new models against a bank of constructed and real social networks to assess model performance. Using simulation, novel new network clustering techniques and extensions of formal diffusion models, this project will develop the tools necessary to interpolate between the simplest direct diffusion cases and the most complex social behavior cases; advances will provide fundamental insights into health- relevant diffusion, yielding more robust modeling and highlighting directions for possible intervention.

Public health relevance
PUBLIC HEALTH RELEVANCE: A wide variety of health outcomes depend on network diffusion; this is clear in cases of direct disease transmission through intimate networks (HPV, HIV, etc.), but also underlies behavioral changes relevant for health, such as dietary practices or knowledge of substance-use risks. We propose a new class of simulation and formal modeling techniques that will allow researchers to understand which how network features affect diffusion in large dynamic networks. Such understanding is necessary to understand health disparities across demographic sub-groups and to build effective diffusion interventions that can protect public health. __SpecificAimsTextDelimiter__ Specific Aims The study of social networks is taking an increasingly prominent role in modeling health outcomes (see figure 1). This rise is partly due to the multiple ways that health diffuses over networks, (Valente and Fosa- dos 2006). First, networks shape health di- rectly through pathogen diffusion, as when a virus is passed through direct social con- tact. In this case, scientific interest lies in predicting diffusion rates and understanding how to minimize transmission by targeting vaccines or behavior modification programs. Second, networks shape health indirectly by the diffusion of health-relevant behavior. Research interest here is in how beliefs and practices relevant for health care are passed through the network, forming the basis of shared norms and knowledge that guide behaviors, such as smoking, diet or exercise (Christakis and Fowler 2007; 2008, Eisenberg et al. 2005). These seemingly different types of network diffusion have a formal similarity rooted in generalized transmission processes over the net- work. In this proposal, we exploit two common network features to unify these disparate areas of health diffusion studies: First, most social networks contain strongly clustered communities with greater internal transmission potential. Second, while social networks evolve dynamically in complex ways across multi- ple relations, individuals are the constant linchpin that unites relations and time, allowing a principled decomposition by time (into "slices") and relations (into "layers) which can be joined through people. Our broadest aim is to provide tools to expand our understanding of diffusion processes on net- works to guide health research. Research has typically faced a "specificity dilemma," choosing between formal models built with unrealistic assumptions and unknown accuracy (Meyers et al. 2005) or detailed simulations with likely accurate mechanisms but idiosyncratic and non-generalizable features (Salathe et al. 2010). We propose integrating computational and formal tools to allow researchers to interpolate along this continuum, so they can know when it is best to use formal models and when it is more appro- priate to build principled simulations. We achieve these broad goals via three practical aims: Aim 1: Design dynamic network community detection tools optimized for diffusion. Diffusion is typically faster within communities (clusters of ties) than between. Analytically, we need tools for detecting dy- namic communities that are optimized for modeling diffusive processes. Empirically, we must improve our understanding of how communities co-evolve with member's behaviors. Solving these problems allow us to make new advances in formal modeling necessary for accurate large-scale studies. Aim2: Extend a principled decomposition strategy for dynamic network diffusion, (a) for simulations and (b) linked to formal models. The specificity dilemma can be solved by unpacking networks by relation, community structure, and time. This allows one to specify diffusion rules, formal model assumptions or simulation parameters, specific to each layer. This approach provides a pragmatic way to estimate and test diffusion scenarios across the complete range of complex diffusion scenarios. Aim 3: Test the simulation and estimation strategies against real-world networks and known diffusion dynamics. We will compile a diverse set of real-world dynamic networks to test the software and evalu- ate our estimation models. Of key interest is distinguishing features that can be approximated with mod- els from those that need explicit network data. Completing these tests is necessary to make the translation from theory to direct public-health relevance.